ALTERED CONTROL OF PERIPHERAL RESISTANCE AFTER PROLONGED BEDREST

This project studies the effects of prolonged bedrest (14 days) on orthostatic intolerance. Specific measurements include sympathetic discharge, norepinepherine spill over and leg vascular resistance during head-up tilt. We are also examining cardiac dimensions and functions in the same individuals. Additionally, sympathetic reflect activation will be examined using leg exercise.